Early Integrated Primary and Specialty Palliative Care for Glioblastoma.

Project Summary
Glioblastomas (GBM) are aggressive, primary malignant brain tumors that are devastating for patients and
caregivers due to high symptom burden, early physical and cognitive decline, caregiver support needs, and
existential distress stemming from life expectancy from diagnosis on the order of months. Palliative care,
defined by the National Quality Forum as “patient and family-centered care that optimizes quality of life (QOL)
by anticipating, preventing, and alleviating suffering” improves QOL and reduces physical and psychological
symptom burden for patients with serious illness. Caregivers of patients who receive palliative care have
reduced distress, anxiety, and depression. Multiple oncological societies recommend that palliative care be
integrated alongside usual oncology care within 3 months of diagnosis into the treatment plan of all aggressive
cancers, including GBM. Yet in patients with GBM, palliative care referrals occur close to death, if at all. This
care gap is likely due to the neurologic and neuropsychiatric symptoms, cognitive deficits, and accumulation of
disability early in the disease course that are characteristic of GBM and differentiate the palliative care needs
of patients with GBM from those in other advanced cancers. Clinicians specializing in palliative care (SPC)
typically have limited training in neurology and neuro-oncology, leading neuro-oncologists to manage palliative
care needs themselves (primary palliative care; PPC). However, time constraints and the prioritization of
cancer-directed therapies limit PPC capacity. Because SPC consultation provides more advanced,
comprehensive palliative care delivery, a model that expands PPC capacity and promotes earlier SPC referral
is needed. Rita “Caroline” Crooms, MD, MPH, developed this proposed career development award to generate
new knowledge about feasibility and acceptability of a novel model that embeds a PPC care navigator and a
SPC clinician into a neuro-oncology practice. Using the Consolidated Framework for Implementation Research
to inform successful intervention design, Dr. Crooms’ aims are: 1) analyze clinical trajectories in GBM and
other high-grade gliomas to identify events (e.g. hospitalization) and patient characteristics (i.e., age,
comorbidities) suggestive of higher palliative care needs to guide timing and content of intervention activities;
2) convene a stakeholder advisory board of patients, caregivers, and neuro-oncology and SPC clinicians to
finalize the intervention protocol and implementation processes; and 3) pilot test the refined intervention in the
neuro-oncology practice of a large, academic health system. Dr. Crooms with her expert mentors/advisors
designed a career development plan to enhance her research skills and facilitate successful completion of the
proposed work. This plan includes training on longitudinal data analysis; stakeholder engagement; and
consensus and clinical trial methodology. This work will provide key preliminary data for Dr. Crooms to conduct
a future R01 multisite clinical trial of the intervention to evaluate its impact on QOL in GBM – and advance her
long-term goal to optimize palliative care delivery for people with brain tumors and their caregivers.

Public health relevance
Project Narrative Glioblastomas (GBMs) are the most common primary malignant brain tumors and cause substantial distress for patients and caregivers due to debilitating neurologic and neuropsychiatric symptoms; cognitive and functional decline; and poor prognosis, with death occurring on the order of months. Palliative care – a medical specialty focused on relieving the suffering associated with serious illness and improving quality of life – is rarely delivered to people with GBM and when delivered in this population, it is late in the illness trajectory. The research objective of this proposal is to identify palliative care needs across the illness trajectory, develop a palliative care intervention based on an analysis of and formal input from patients, caregivers, and health professional stakeholders and pilot test the refined intervention with timing and content tailored to the GBM context.